Women Living with HIV: Cognitive Impact of Estrogen Receptors, Inflammation, and Aging

Project Summary/Abstract
Cognitive impairment is prevalent in older adults and females carry a disproportionately greater risk for
cognitive deficits like dementia and Alzheimer's disease. While estrogen deficiencies have been linked to an
increased risk of cognitive decline, the mechanism for this remains unclear. Evidence suggests that women
living with HIV (WLH) are more likely to experience an earlier onset of menopause, thereby reducing the
circulating estrogen levels. Additionally, within the population of people living with HIV (PLWH), women are at a
higher risk for developing cognitive decline which tracks with data seen in the general population of people
living without HIV. Thanks to the advancement of HIV treatments, PLWH are living longer, adding to the
urgency to identify mechanisms underlying the acceleration of cognitive decline. The goal of this proposal is to
determine the extent to which estrogen receptor expression and function predict cognitive decline in WLH.
Leveraging the framework of the Atlanta Women's Interagency HIV Study (WIHS) cohort and the Emory
SCORE U54, this project will test the hypothesis that HIV serostatus interacts with menopause to alter
estrogen receptor subtype expression and that changes to estrogen receptor β are predictive of inflammatory
and cognitive outcomes. Aim 1 will focus on the characterization of estrogen receptor subtype protein
expression in PBMCs to establish a metric for understanding the expression of the two prominent estrogen
receptor subtypes (α and β) and how they differ in the context of menopause and HIV. Aim 2 will establish
inflammatory and cognitive profiles for the study participants using longitudinal timepoints to illuminate changes
in both inflammatory and cognitive states that can be tracked over time. Data resulting from the evaluation of
estrogen receptor subtype expression in the context of menopausal status and HIV status, coupled with the
cognitive data available through WIHS will enrich our understanding of the role of estrogen receptors in
predicting cognitive decline, and potentially inform biomarker selection for screening women who are at higher
risk of developing cognitive impairment, especially WLH. This research and training will be performed with Dr.
Gretchen N. Neigh, Ph.D., at Virginia Commonwealth University. The training provided will build upon the
applicant's technical, computational, and molecular skills, in addition to providing targeted professional
development opportunities, and further training in hypothesis-driven project design. Ultimately, this training will
prepare the applicant for a future as an independent physician-scientist, investigating factors that impact
cognition with aging.

Public health relevance
Project Narrative Women living with HIV (WLH) are at a disadvantage in that they are more likely to experience menopause at an earlier age in addition to their biological sex increasing their likelihood of developing cognitive impairment. Because evidence has implicated estrogens as neuroprotective mediators for cognitive health, this proposal aims to investigate the role of estrogen receptors in mediating cognitive decline in WLH, utilizing menopausal status along with age to account for different stages of the aging process. Resulting data may point towards utilizing estrogen receptor levels in peripheral blood mononuclear cells (PBMCs) as a biomarker for identifying WLH who are at a higher risk for developing cognitive deficits.